3D Whole-Pancreas Analysis of Mouse Models of Pancreatic Cancer

Project Summary
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
23-045 and is a collaboration between the Cellular Cancer Biology Imaging Research (CCBIR) Program and
the Pancreatic Ductal Adenocarcinoma Stroma Reprogramming Consortium (PSRC). Pancreatic cancer is a
deadly disease with a dismal prognosis but arises from precancerous lesions that lack the ability to spread
beyond the pancreas, underscoring the opportunity for cancer interception in this disease. Genetically
engineered mouse models provide a key opportunity to study premalignant pancreatic tumorigenesis over time
to provide a rational foundation for such interception approaches, as serial tissue samples from these time
points are not available from human patients. However, tools to quantify precancer burden in mice at the
single-cell level through the whole pancreas are currently lacking; such tools would greatly improve the rigor of
evaluation of these models. As such, we will leverage our recently developed deep learning tool CODA for 3D
reconstruction and cellular quantification, which is undergoing expanded application and validation as part of
the CCBIR Program. Using CODA, we will analyze whole pancreata from the inducible KRAS (iKRAS) mouse
model, which allows assessment of epithelial-microenvironment cross talk at multiple time points in early
tumorigenesis, a key goal of the PSRC. This collaboration between the CCBIR Program and the PSRC will
apply novel cancer imaging technologies to innovative mouse models of pancreatic cancer, providing important
insights into the cellular alterations in early pancreatic tumorigenesis. These studies will also provide additional
validation of the CODA pipeline and poise this approach for application more broadly across mouse models of
cancer.

Public health relevance
Project Narrative We propose to combine innovative 3D tissue modeling approaches with genetically engineered mouse models of early pancreatic tumorigenesis to quantify cellular alterations over time, at the single-cell resolution throughout the entire pancreas. This novel tissue analysis pipeline will provide key insights into pancreatic cancer biology and will be poised for application across other murine cancer models.